Therapeutics targeting TDP-43 to treat Alzheimer's disease and related disorders

TDP-43 is a mixed proteinopapthy in Alzheimer’s disease (AD), AD-TDP, based on substantial epidemiological
data correlating TDP-43 inclusions with cognitive decline in AD patients. TDP-43 associated AD has been
termed as limbic-predominant age-related TDP-43 encephalopathy (LATE) as well as other acronyms,
underlying the newly-recognized importance of TDP-43 in AD (AD-TDP). AD is the most common cause of
mid- to late-life cognitive impairment and dementia, afflicting ~30 million people worldwide Based on an
extensive review of clinical and pathological studies, TDP-43 proteinopathy is associated with an amnestic
dementia syndrome that occurs in older adults. A statistical analysis of attributable risk suggests that TDP-43
associated AD is a major public health issue accounting for up to 20% of cases of clinically diagnosed AD
dementia. This TDP-43 proteinopathy is a distinct clinical and pathological entity from other TDP-43
associated diseases that may also be treatable with a TDP-43 targeted therapy, such as amyotrophic lateral
sclerosis (ALS) and certain forms of frontotemporal lobar degeneration (FTLD-TDP). Therefore, successful
completion of this project has the potential to identify TDP-43-based therapeutics for the treatment of other
diseases where TDP-43 plays a major and causative role. We have discovered small molecules that bind to
TDP-43 in such a way as to inhibit binding of RNA to TDP-43 and prevent TDP-43 aggregation, with activity
suggestive of a therapeutic effect in three models: (1) human wild-type and mutant TDP-43 expressed in
Drosophila, (2) induced motor neurons (iMNs) from C9orf72 patient-derived iPSCs, and (3) mice expressing
human TDP-43 (Thy1 promotor). Evidence from 2-D NMR studies and computational docking analysis
suggests that these inhibitors are binding to ribonucleotide recognition motif RRM2 which contains one of the
amino acids involved in a critical and functionally-relevant salt bridge with RRM1. A recent PET imaging study
describes a metabolic marker to potentially select AD-TDP patients for clinical trials based on ratios of FDG
imaging in different regions of the brain. In this project we seek to discover, validate and develop new small-
molecule inhibitors of nucleic acid binding to TDP-43 and TDP-43 aggregation inhibitors to treat AD-TDP. Aim
1 is the optimization of in vitro potency and drug-like properties of novel TDP-43 ligands including penetration
into the brain and acceptable half-life and safety measures using a comprehensive battery of pharmaceutical
industry-standard assays and criteria. Aim 2 involves target engagement studies using hTDP-43 transfected in
HEK293T cells, patient-derived induced motor neurons from iPSCs, dynamic light scattering analysis of
aggregation, and X-ray crystallography of ligands bound into TDP-43. Aim 3 is evaluation in animal models of
TDP-43 pathology, initially using a Thy1 promoter followed by a hTDP-43 based mouse model that
demonstrates cognitive impairment in the absence of locomotor deficits. Aim 4 includes IND-enabling studies,
scale-up synthesis, multi-species PK and rodent toxicity.

Public health relevance
Alzheimer’s disease (AD) is the most common cause of mid- to late-life cognitive impairment and dementia, afflicting ~30 million people worldwide. TDP-43-associated AD (AD-TDP), also called Limbic-predominant Age- related TDP-43 Encephalopathy or LATE, is a recently recognized AD subtype that may be treatable with TDP- 43 targeted therapy. We are developing small molecule inhibitors of nucleic acid binding to TDP-43, which are also TDP-43 aggregation inhibitors, showing therapeutic-like effects in three biological models, to treat AD- TDP and related disorders.